Circadian Pathways Linking Metabolic Homeostasis and Gene Regulation During Aging

PROJECT SUMMARY / ABSTRACT
Aging is characterized by a progressive decline encompassing a number of hallmark processes. Particularly,
age-related abnormalities in energy metabolism entail dysregulated nutrient sensing and mitochondrial function,
contributing to the overall decline in physiology and behavior. The circadian clock is a network of cellular
oscillators driving output gene expression with ~24 hr rhythmicity, and plays a fundamental role in energy
homeostasis. During aging, the clock and clock-controlled output rhythms also display attenuated oscillatory
amplitude and resilience, contributing to metabolic decline. The ROR (Retinoid acid receptor-related Orphan
Receptor) subfamily of nuclear receptors are key components of the circadian oscillator that function to sustain
robust oscillatory amplitude and drive circadian gene expression via transcriptional and epigenetic mechanisms.
We previously identified a natural agonist of RORs from chemical screening and demonstrated an important role
of RORs in metabolic regulation and aging physiology. More recently, we generated skeletal muscle specific
knockout of RORs (alpha and gamma subtypes) in mice (Ror mDKO), and phenotypic characterization of adult
Ror mDKO mice (up to 8 months of age) revealed a strong effect on skeletal muscle metabolism and function.
Based on these exciting preliminary results, we hypothesize that the circadian clock, particularly RORs, regulate
aging-related metabolic functions via gene regulatory mechanisms, and play a pivotal and modifiable role in
healthspan and lifespan. In Aim 1, utilizing the aforementioned Ror mDKO mice at old ages, we will evaluate the
role of RORs in healthspan and lifespan. In Aim 2, combining physiological, molecular and omics approaches,
we will determine regulatory pathways by which RORs orchestrate energy metabolism and mitochondrial
function in aged control and Ror mDKO mice, and delineate transcriptional and epigenetic mechanisms. In Aim
3, we will perform two circadian lifestyle interventions, namely time-restricted feeding (TRF) and timed exercise
(TE) corresponding to temporally controlled energy intake and expenditure respectively, and evaluate whether
RORs are required for healthy aging effects of these lifestyle interventions. Together, the proposed studies will
provide key mechanistic insights on the role of the clock in the crosstalk among metabolic and gene regulatory
hallmarks of aging, and pinpoint RORs as an actionable target for novel therapeutic strategies to activate clocks,
delay aging and prolong healthspan. The innovations include a conceptual paradigm where circadian
mechanisms orchestrate aging hallmarks, a novel KO mouse line, and circadian lifestyle interventions to promote
skeletal muscle health and overall healthspan. We have assembled an excellent team of co-Investigators with
complementary expertise and demonstrated track record in aging, circadian rhythms, metabolism, gene
regulation/epigenetics, and interventions. Given the pressing lifestyle-related health challenges and a rapidly
aging society, the proposed study may have profound basic and translational impact, eventually leading to
improved quality of life in the elderly population.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Our modern 24/7 lifestyle is accompanied by prevalent circadian disruption, compromising metabolic and physiological health in an increasingly aging population. Focusing on metabolic dysregulation as an underlying cause for various age-related hallmarks, the current project will interrogate circadian (epi)genetic mechanisms and explore properly timed eating and exercise to promote skeletal muscle health and overall healthy aging. These studies promise to elucidate novel regulatory mechanisms and actionable strategies to improve quality of life in the elderly.